Discovery and development of apoE4 correctors for the treatment of Alzheimer's disease

PROJECT SUMMARY
Alzheimer's disease (AD) is a major public health crisis with no effective treatments. Apolipoprotein E (ApoE)
has three major polymorphic alleles, denoted ApoE2, ApoE3, and ApoE4. Homozygosity for ApoE4 is the
strongest genetic risk factor for AD with an astonishing 12-fold increased risk of developing AD compared
with individuals who inherit ApoE3.1,2 ApoE4 differs from ApoE3 by a single amino acid, an arginine instead of
cysteine at position 112. This small change presumably alters the conformation of the protein, altering its
activity in many biological pathways resulting in both gain and loss of function.1,3 Given the dramatic impact of
ApoE4 on AD biology (including increased amyloid deposition, faster rate of progression, decreased synaptic
content), there have been attempts to identify a small molecule that binds to ApoE4 and makes it functionally
similar to ApoE3, a so called “corrector”. Yet this has been challenging: Generating purified ApoE4 protein has
proven to be difficult, as the protein is notoriously sticky and readily aggregates. Multiple mutations in the C-
terminal region are required to enable ApoE purification and structural determination.4 Biophysical analysis of
this purified but modified protein gives insight into the consequences of the single amino acid change,
suggesting that the thermal stability of ApoE4 is notably less than ApoE3.5 We now approach this challenge to
take advantage of an emerging technology to analyze thermal stability of proteins in the context of tissues,
intact cells and lysates called cellular thermal shift (CETSA).6 Analysis of lysates from the brains of humans or
humanized ApoE transgenic animals by CETSA showed that brain ApoE4 is less thermally stable
compared to ApoE3. We have reproduced this same phenotype in transfected human HEK cells and by
engineering a HiBiT tag on to the N-terminus of ApoE4, creating a split Nano-luciferase cellular thermal shift
assay (BiTSA)7,8 that is suitable for both identifying novel correctors, through a high throughput (HTP) screen,
and driving subsequent hit to lead efforts. Excitingly, we show that both a recently published ApoE4 corrector
(compound 8), discovered by scientists at AbbVie by an NMR fragment screen and structure guided chemistry
effort, and a previously published genetic “corrector” – the Arg61T mutation, fully restore the temperature
stability of ApoE4 such that it performed like ApoE3 in the BiTSA assay. Compound 8 has a KD <5 μM9. We
have already made a small library of analogues, reproducing the effect with some potential insight into
improvements. The aims of this application are to 1) leverage the ApoE BiTSA assay to identify novel
ApoE4 correctors, through an HTP screen, 2) drive medicinal chemistry optimization of compound 8 and
hits identified in the screen and 3) test the hypothesis that these correctors can ameliorate ApoE4
related Alzheimer phenotypes both in vitro and in vivo using cell and murine models that we and others
have developed. These efforts represent initial steps towards our overall long-term objective, discovering
first in class ApoE4 correctors as therapeutics to prevent AD.

Public health relevance
PROJECT NARRATIVE APOE4 is the greatest known genetic risk factor for sporadic Alzheimer's and there exists a high unmet medical need for therapeutics that could prevent disease associated with this variant. We have developed an innovative split luciferase assay that can detect the binding of compounds to ApoE4 in cells. We propose to leverage this breakthrough to both discover new and optimize known ApoE4 correctors into drugs that can generate in vivo proof of concept that they can functionally correct ApoE4 pathobiology in murine models and ultimately be developed into a therapeutic for AD.